MEASURING SUBSTANCE ABUSE AMONG THE DEAF

Literature suggests that substance abuse is as prevalent among the deaf as in the general population. To date, there are not empirical data regarding substance abuse by this population from which to draw valid epidemiological conclusions. It is probable that the number of deaf substance abusers exceeds all previous speculation. Reasons for lack of epidemiologic data about substance abuse among the deaf are: 1. Lack of literacy skills makes it difficult for them to be surveyed. The average reading level is grade 3.5, and deaf adults do not understand more than 26% of one-to-one conversation through lip reading. Therefore, surveys must be done in sign language. 2. There has been massive denial by the deaf community regarding the issue of substance abuse and resistance to being surveyed about any behavior that may carry stigma. They express fear that a dual stigma of "deaf and drunk (drugged)," will be imposed upon them. This Phase I application tests the feasibility of interviewing deaf persons using visual/sign language questionnaires with interactive videodisk technology in two sign language modalities (American Sign Language, Signed Exact English) to learn ways to overcome resistance within the deaf community as well as knowledge about their substance use.